PRENATAL COCAINE AFFECTS BREATHING AND STATE DEVELOPMENT

The purpose of this study is to identify early risk markers for SIDS by evaluating the fetus, newborn, and infant of mothers who abuse cocaine compared to two control populations; a drug and tobacco-free group, and a drug-free but tobacco-using group. Physical growth, dimensions of neurobehavioral/psychological functioning, respiratory control and state development will be assessed.